Developing and testing health warning labels on the ENDS device

Developing and Testing Health Warnings for ENDS
PROJECT SUMMARY
The use of electronic nicotine delivery systems (ENDS or e-cigarettes) has reached epidemic levels among
young people in the United States (US). ENDS emit toxic substances, including nicotine that irreversibly affects
youth’s developing brain leading to dependence and increased risk of cigarette smoking initiation, yet
misperceptions about their safety are widespread. Therefore, health communication of ENDS-related risks
through Health Warning Labels (HWLs) has been considered as a priority by leading health and regulatory
bodies in the US to reduce ENDS use among young people. We have developed and pilot-tested a clinical lab
model to examine the potential effects of pictorial HWLs on young (21-29 yrs) ENDS users’ experiences. In this
proposal, we will use this model coupled with a systematic development of ENDS pictorial HWLs to test their
effect when they are placed on the device on a variety of subjective (e.g. satisfaction, harm perception, nicotine
dependence, intention to quit) and objective outcomes (e.g. plasma nicotine, puff topography). This will be
done in three stages. First, we will review the literature and develop candidate messages and their associated
pictures for the HWLs (n=45). This initial set of HWLs will then be revised and ranked through a Delphi study
among tobacco control, regulation, and health communication experts. Second, we will conduct focus groups
with young ENDS (21-29 yrs) users to adapt the candidate HWLs to our target population and device itself.
Third, we will test HWLs on the ENDS device in a clinical lab cross-over study, where each subject uses ENDS
in 2 sessions; 1) their preferred product without HWL (control), and 2) their preferred product with pictorial
HWL on the ENDS device. This design will allow us to test our main hypothesis; compared to control, using
ENDS with the HWLs is associated with decreased satisfaction, dependence suppression, and puffing
behavior, but increased knowledge about harm and intention to quit. This project will guide policymakers into
the application of effective HWLs for ENDS and will develop warning messages and pictorials that national and
state stakeholders can use through different modalities in counter-marketing campaigns to protect young
people and discourage harmful ENDS use.

Public health relevance
PUBLIC HEALTH RELEVANCE The use of electronic nicotine delivery systems (ENDS or e-cigarettes) has reached epidemic levels among young people in the US. ENDS use among young people is driven in part by misperceptions of their safety. Health communication of ENDS-related risks is a priority, and this proposal focuses on developing and testing health warnings for young ENDS users.